2025 Patrica Levy Zusman International Workshop on Neuroregeneration

Project Summary/Abstract
This R13 resulted from discussions between investigators in the fields of neurostimulation and neuroplasticity at
the Houston Methodist Research Institute (HMRI). In 2017, we held an R13-funded pilot workshop that combined
research in neural stimulation with new insight into the molecular understanding of neural plasticity and
regeneration. The workshop received a strong, positive response by participants and interest in further catalysts
for working collaboration. Thus, in 2019, we fostered relationship development and crossover opportunities
among attendees via a blitz session wherein newly formed (i.e., established at the 2019 Workshop) collaborative
teams competed for two $5K mini grants that supported travel to and from each other’s institutions. In 2021, we
went 100% virtual due to COVID-19, however, this did not diminish the R13-funded Workshop’s impact. In 2023,
our R13-funded workshop returned to an in-person event, bringing with it many of the successful virtual tools
from 2021. On March 4th – 6th, 2025, we will host the 5th Patricia Levy Zusman International Workshop on
Neuroregeneration (Zusman Workshop), which will focus on the intersection of electrical activity, brain
connectomics, and molecular neural plasticity. Our specific aims are to: 1) formulate new ideas to fill the gap
between physiology and functional-based brain stimulation technologies and the molecular and cellular
understanding of innate neuronal plasticity; 2) provide promising trainees with various avenues to present their
work; and 3) ensure trainees participate in substantial discussions and interactions with faculty members. The
2025 Workshop will be held at HMRI, which is part of the Texas Medical Center (TMC; a one-of-a-kind medical
and research hub that fosters cross-institutional collaboration, creativity, and innovation) and is in Houston,
Texas (one of the United States’ most diverse cities). A key aspect of the Zusman Workshop is the active
inclusion and participation of trainees, particularly women and under-represented minorities. We will encourage
their participation via travel scholarships and active promotion and recruitment throughout the TMC. The
Workshop promotes the voices of graduate and postdoctoral trainees by including a trainee poster session as
well as a session dedicated to trainee oral presentations (given by travel awardees). Further, goal-oriented
breakout sessions, led by senior/early-stage investigators and selected trainees, will foster discussion and
promote cross-training and collaboration among participants. Overall, this workshop distinguishes itself from
established physiology conferences and dedicated neural regeneration conferences by being 1) highly focused
on the gap between molecular regeneration and electrophysiology/stimulation, 2) concept driven by clinicians
and experimentalists currently problem solving in human therapy, and 3) focused on the establishment of cross
training and expertise development in graduate, post-graduate, and clinical fellows. The 2025 Zusman Workshop
will ignite nascent collaborations and spur novel multidisciplinary teams to develop innovative, transdisciplinary
methods, technologies, and treatments to modulate performance in the damaged nervous system.

Public health relevance
Project Narrative An unintended chasm exists between researchers examining the mechanisms of neural regeneration through molecular approaches with those applying cell and system level neural activity to modulate performance in the damaged nervous system. To bridge the gap between these research realms, in 2017, we developed and held the first biennial Patricia Levy Zusman International Workshop on Neuroregeneration, which focused on the intersection of electrical activity, brain connectomics, and molecular neural plasticity. In 2025, our goals are to 1) build upon the success of our previous four workshops by inviting back and sponsoring travel for rising star alumni to return and participate; 2) create an interdisciplinary discussion of the gap in these disciplines, and 3) stimulate working groups, training opportunities, and translational approaches to speed progress in directed, stimulation-based regenerative therapies.